High sensitivity NMR for structure determination of neurodegenerative disease associated protein aggregates in native contexts

Per SPA document not needed

Public health relevance
Per SPA document not needed